Robotic Point-of-Care OCT

PROJECT SUMMARY/ABSTRACT
The PI was previously funded by the F30 mechanism while completing the Duke Medical Scientist Training
Program. He has since completed medical school and internship and now returns for a full-time research career.
This career development proposal is an effective continuation of the PI’s prior mentored training and research
experience and seeks to develop him into an independent investigator. The proposed project concerns the role
of optical coherence tomography (OCT) in retinal disease screening. Preventable retinal blindness affects tens
of millions of Americans and hundreds of millions worldwide. Its top three causes are chronic, progressive
conditions that yield irreversible vision loss after an initial asymptomatic period. Annual screening is therefore
essential to detect and treat these diseases before sight deteriorates. Rates of screening are suboptimal,
however, because the proper eye examination is difficult for and inaccurate when performed by primary care
providers (PCPs). OCT is an essential imaging modality for management of retinal diseases. Currently, clinical
OCT is deployed as bulky tabletop instruments that require trained ophthalmic photographers, dedicated imaging
suites, and mechanical head stabilization with chinrests for operation, which has prevented OCT-based eye
screening by PCPs. We recently introduced robotic point-of-care OCT (RAOCT) as a fundamentally new
paradigm for OCT-based eye examination that overcomes the barriers that restrict OCT to ophthalmology offices.
RAOCT offers semi- or fully-automated non-contact OCT imaging by bringing a robot-mounted OCT scanner to
the patient, tracking them throughout a large imaging workspace, and optically correcting for motion artifact. Our
laboratory prototypes using this approach have demonstrated sufficient OCT quality in freestanding and seated
subjects for anatomic measurement and clinical correlation, respectively, with only minimal operator training.
These prototypes function reliably only under controlled laboratory conditions, however, and significant
technology development for portability, tracking robustness, and motion correction is necessary to yield a clinic-
ready instrument. This project therefore seeks to advance our bench-mounted prototypes into fully-fledged
mobile systems for imaging in non-specialist clinics and to test them against the OCT standard-of-care. First, we
will transition our prototype into a wheeled cart that can be brought into clinics, upgrade our robot arm for
extended reach, and redesign our robot-mounted scanner for improved tracking under realistic imaging
conditions. Next, we will enhance motion attenuation by transitioning image processing algorithms to dedicated
hardware, by adding digital correction for residual motion, and by incorporating a novel adaptive scanning
technique to reduce imaging time. Finally, we will perform RAOCT imaging in ophthalmology clinics to compare
against the standard of care and in primary care offices to evaluate screening workflows. Completion of this
project will develop robotic point-of-care OCT into a turnkey imaging platform that promises to enhance eye
screening in primary care settings.

Public health relevance
PROJECT NARRATIVE Optical coherence tomography (OCT) is an essential imaging technique for management of many common eye conditions, including diabetic retinopathy, age-related macular degeneration, and glaucoma. OCT has a limited eye screening role outside of ophthalmology offices due to personnel and training barriers, however. This project seeks to develop a robotic point-of-care approach for semi-automated OCT imaging that may eventually enable chronic eye disease surveillance in primary care offices and non-specialist clinics.